Administrative Core

This application proposes to continue a successful collaborative partnership between North
Carolina Central University (NCCU) and the UNC Alcohol Research Center (UNC ARC) in
response to RFA-AA-21-015. NCCU, founded in 1910, is a Historically Black College or
University (HBCU) that has partnered with the UNC ARC since 2010; this partnership
contributed to the enrollment of NCCU’s first PhD students in 2012 and to several of the current
10 PhD graduates. NCCU is a comprehensive institution offering bachelor’s degrees and
graduate degrees, with 80% of NCCU students being underrepresented minorities (African
American or Hispanic). NCCU is located near the University of North Carolina at Chapel Hill and
the UNC NIAAA Alcohol Research Center, which has been funded since 1997. The previous
UNC-NCCU partnership involved 10 NCCU biomedical faculty in alcohol research (about 30%
of NCCU faculty laboratories), with up to 15 students each year contributing to 37 publications
and three funded NIAAA R grant applications. None of this occurred prior to this partnership.
This U54 Administrative Core proposes to continue to build and promote alcohol research
expertise and to develop research infrastructure and capacity, particularly for health disparities-
associated pathology. Further, the Administrative Core will develop and administer collaborative
education-training of URM NCCU students in UNC ARC labs and other UNC training activities.
This will be accomplished through 5 aims: Aim 1: Provide scientific and administrative
leadership; Aim 2: Monitor and enhance collaborative partnerships; Aim 3: Mentor leadership
among faculty; Aim 4: Support the Scientific Mentoring and Research Experiences Core; and
Aim 5: Recruit NCCU laboratories to alcohol research. Through structured mentoring and
experimentation, this proposal will create successful alcohol research programs, leading to both
discoveries and the education of large numbers of URM students on health disparities
associated with alcohol use disorders.